Gardner Lab MIRA Proposal: Microtubules and Mitosis

The Gardner Laboratory uses a combination experimental and computational approach to
dissect molecular mechanisms for how microtubule lengths are regulated inside of cells. We use
biophysical computational modeling to better integrate and understand our experimental
observations, make new experimental predictions, and to test whether our proposed cellular
mechanisms are physically reasonable. Overall, we are a cellular biophysics laboratory that
combines cell biology tools with biophysical methods to shed new light on the regulation of
microtubule dynamics during mitosis. Achieving the goals described in this application will allow
us to expand the sources of tubulin that can be used for imaging of microtubule dynamics, thus
establishing stronger connections between cellular and organismal phenotypes, especially
through the use of targeted mutagenesis. Our first project will involve the pathogenic yeast
Candida albicans. Thus, we will advance our understanding of (a) how C. albicans microtubule
dynamics compare to mammalian microtubule dynamics, (b) how a range of current
microtubule-targeting drugs differentially alter microtubule dynamics in C. albicans relative to
mammalian tubulin, and (c) how changes in microtubule dynamics parameters lead to the
disruption of cell division in the pathogenic yeast C. albicans, as compared to in human cells.
Further, we expect that computational modeling and ultrastructural analysis of C. albicans
tubulin will allow us to connect molecular-level and cellular-level drug phenotypes and
outcomes.

Public health relevance
Mitosis is the process by which duplicated sister chromosomes are evenly distributed to identical daughter cells, and in cancer cells, improper chromosome segregation during mitosis (e.g., such that chromosomes are unevenly distributed between daughter cells) is widely observed, and has been linked to poor prognosis, including decreased overall survival time and fewer treatment free years. In this study, we will make use of physical principles and advanced microscopy to evaluate the role of controlled forces in ensuring proper chromosome segregation during mitosis, and to dissect the role of microtubule structure in the targeting of microtubule- associated proteins. The results generated from our studies will be applicable both towards better understanding the fundamental biophysics of cell division, and also towards providing mechanistic information to shed light on current cancer therapies.